Objective Physical Activity and Cardiovascular Health in Older Women: OPACH2

Despite higher rates of incident or recurrent MI and fatal coronary heart disease (CHD) among women aged 85
and older (120/1000) than men (85/1000), and the disproportionate burden of disability and co-morbidity in
aging women related to diagnosed and occult cardiovascular disease (CVD), prevention of CVD in this
vulnerable population is vastly understudied. This application builds upon the now completed Objective
Physical Activity and Cardiovascular Health (OPACH) Study (NHLBI R01 HL105065), ancillary study
embedded in the Women’s Health Initiative Long Life Study led by Dr. LaCroix. The OPACH team studied
accelerometer-measured physical activity (PA) and sedentary behavior (SB) in relation to incident CVD among
7048 women ages 63-99. Our primary results showed a statistically significant, dose responsive, 20%
reduction in incident CHD, a 10% reduction in incident CVD, and a 24% reduction in all-cause mortality for
every additional hour spent in light PA (1.6-2.9 METs) in older women; and a 12% increased risk of CVD for
every additional hour spent sedentary. To classify light PA, the OPACH team conducted a laboratory
calibration study (200 OPACH women) to determine accelerometer cutpoints for absolute intensity relevant to
the usual daily PA habits of older women. Age-specific classification of PA intensity is critical because resting
metabolic rate and maximal aerobic capacity decline with aging, whereas the energy cost of aerobic activity
increases with age. Because of these age-related changes and the heterogeneity in how they occur in older
adults, the 2018 PA Guidelines Evidence Report urged researchers to: “Conduct prospective cohort studies of
PA and physical function in older adults that include objective measures (e.g., heart rate monitors) of relative
intensity of PA.” The term “relative” in this context refers to the maximal exercise capacity of individuals.
OPACH2 and the OPACH2 Calibration Study are designed specifically to derive validated accelerometer-
measured PA relative intensity and determine its association with incident CVD (CHD, heart failure, stroke) and
mortality through 2027. To do this, we will obtain a second accelerometer measurement of PA and SB with
contemporaneous measurement of heart rate (a physiological measure of PA intensity) using a non-invasive
cardiac monitor patch (Cardea SOLO) in 4200-5000 surviving OPACH women. We will also investigate cross-
sectional associations at the second accelerometer wear (2022-2023) of relative and absolute PA intensity with
indicators of underlying CV health including traditional risk factors (lipids, glycemia, inflammation, blood
pressure, adiposity), novel biomarkers of CVD pathology (cardiac troponin, brain natriuretic peptide, galactin-
3), heart rate variability (from Cardea SOLO patch), and physical performance. Finally, we will determine the
association of changes in accelerometer-measured PA and SB over ≈10 years with changes in traditional
cardiovascular risk factors, novel biomarkers, and physical functioning during the same interval, and with
incidence of clinical CVD events and mortality through 2027.

Public health relevance
OPACH2 is a prospective study of 6489 women (50% of whom are black or Hispanic) initially aged 63-99 years who wore a small device on their hip for 7 days in 2012-2014 to measure movement and sitting during their usual activities. The study is designed to investigate and compare different measures of physical activity intensity across the full range of effort from sitting still to light to moderate to vigorous activity taking into account a woman’s maximum effort possible. We propose to compare how strongly different physical activity intensity measures predict the occurrence of new cardiovascular disease events (heart attacks, heart failure, stroke) and mortality, as well as several indicators underlying cardiovascular health including traditional risk factors like blood cholesterol levels, newer blood measures of heart injury (cardiac troponin, natriuretic peptide, galactin-3), changes in heart rate regulation (heart rate variability) and tests of physical functioning.